Post-translational mechanisms of cardiac adaptation during unloading

PROJECT SUMMARY
Cardiovascular diseases are responsible for more deaths each year than cancer, which is why it is important to
study how to keep hearts healthy. Hearts undergo physiological remodeling; this is a structural and functional
adjustment that matches contractile capacity to hemodynamic demand. In cardiomyocytes, hormonal and
mechanosensitive signaling pathways maintain the balance between normal cell size, hypertrophy, or atrophy.
Pathologies develop when the adequate adaptation to a stimulus is mismatched. My long-term goal is to
establish an independent research program on understanding how mechanical load affects myocardial
structure and function and what are the contributing molecular mechanisms. My recent publication in the
Journal of General Physiology shows that changing mechanical stimulus of cardiac myocytes affects the
dynamics and post-translational modification of the Z-disc actin-capping protein CapZ. I wish to extend this in a
new direction working as an independent investigator. Accordingly, my central hypothesis is that mechanical
load of cardiomyocytes regulates protein homeostasis in sarcomeres through the balance between acetylation
and ubiquitination of lysine residues. Histone deacetylase 3 (HDAC3) is one known acetylation enzyme of
sarcomeric proteins. I focus on the Z-disc proteins CapZ and α-actinin because they both maintain sarcomere
integrity and because acetylation sites have been previously found in both proteins. My preliminary data shows
that unloading changes the relative abundance of CapZ and α-actinin ubiquitination and acetylation. The goal
of the K99 mentored phase is (1) to determine post-translational modifications arising from chemical or
mechanical unloading of isolated cardiomyocytes with focus on acetylation and K48-oligo-ubiquitination. The
goals of the R00 independent phase are (2) to characterize how HDAC3 activity in cardiomyocytes regulates
α-actinin and CapZ deacetylation with varying mechanical load and (3) to determine the changes in post-
translational modification of sarcomeric proteins by HDAC3 during left-ventricular unloading in whole hearts.
The innovation of this project lies in the combination of cardiomyocyte mechanobiology with post-translational
molecular biochemistry to understand how cardiac cells maintain sarcomeric protein balance through the
ubiquitin-acetylation pathway in response to mechanical stimuli. The outcomes of this project will expand our
knowledge about the signaling pathways responsible for modulating protein homeostasis in cardiomyocytes
that may develop new research lines for regulation in hypertrophic cardiomyopathies and sarcopenia. The
career development activities in this proposal, in addition to the exceptional mentoring team and research
environment at the University of Illinois at Chicago, will support my successful transition to a career as an
independent investigator.

Public health relevance
PROJECT NARRATIVE The well-known “use it or lose it” principle is that weight lifting builds muscle mass (hypertrophy) while unloading results in loss of mass (atrophy), but the molecular mechanisms regulating these changes are poorly understood for loading, and almost non-existent for unloading. We use heart cells in culture in models of loading and unloading to determine how the muscle proteins, CapZ and α-actinin, are chemically modified by ubiquitination or acetylation to regulate muscle mass. This project provides career training that may lead to new research lines for regulation in hypertrophic cardiomyopathies and sarcopenia.